Designing a Robust Platform for the In vitro Propagation of Babesia Microti in Human RBCs

The overall goal of the R61 phase of our proposal is to establish a continuous in vitro culture system of B. microti
in human RBCs to enable a platform amenable for future experimental investigation, specifically the identification
and characterization of human RBC receptor-B. microti ligand interactions that facilitate parasite invasion which
will be explored in the R33 phase. We hypothesize that B. microti like other erythrocyte seeking protozoans
have preferential cellular invasion and proliferation needs. To establish if this is true, we will in the R61
phase, Milestone1, analyze the parasite-hosting capabilities of sub-populations of RBCs using separation and
purification protocols from peripheral blood, umbilical cord blood and hemochromatosis blood draws, using
parasite inoculum from both B. microti infected mice and infected human sources. We will also analyze pure
populations from erythroid progenitor cells that have been FACS sorted for the ability to be infected with B.
microti. Once a specific host RBC has been identified along with the inoculum, we will assay culture media along
with serum/lipid additives and vitamin/mineral additives, and ideal gas conditions, to achieve Milestone 2.
Working with the highest infection achieving media, host RBC and parasite source, we will monitor parasite
egress and re-invasion after ensuring adequate host RBCs that the parasite requires, in culture, in Milestone 3.
FACS and Giemsa estimation of parasitemia and overall culture dynamics will be constantly monitored, paying
particular attention to sub-population structure of the cultures, which will inform us of success of various
Milestones. As part of Milestone 4, we will cryopreserve and revive stocks of culture-adapted parasites.
Comprehensive Bio-Protocols will be written up detailing specific aspects of each step in the culturing process.
Once an in vitro culture system is in place critical aspects of human host-parasite relationships can be explored
and we will investigate B. microti invasion of the human RBC, in the R33 phase. To identify and characterize
RBC surface molecules that function in invasion, we will use enzymatically treated RBCs, clinically defined RBCs
deficient in specific receptor, inhibition of invasion assays using antibodies/peptides and forward genetic
approaches using shRNA mediated knockdown of specific RBC receptors. Cognate B. microti ligands will then
be identified using gel overlay and pull-down assays. Validation of these receptor-ligand interactions will be
carried out via AVEXIS and BIAcore assays. Functional validation assays will include inhibition of invasion
assays with anti-ligand antibodies and recombinant ligand proteins. We believe that these innovative approaches
will greatly enhance the opportunities and capabilities for investigations into B. microti biology.

Public health relevance
Human babesiosis is caused by Babesia microti, a tick-borne intraerythrocytic parasite, and is a global public health concern. This application is the first systematic analysis of culture conditions required for B. microti propagation in human RBCs and is a necessary first step in the search for reagents for diagnosis, epidemiology, treatment, and prevention of human babesiosis.